Social connections, risk for COVID-era psychiatric and substance use disorders, and HIV control

PROJECT SUMMARY / ABSTRACT
Social connections are critical to human well-being, and people lacking in these connections (social isolation)
or who perceive that they are lacking these connections (loneliness) have lower self-management of chronic
disease, are more likely to suffer from substance abuse disorders and depression, and are at higher risk for
premature mortality. People living with HIV report a significant burden of loneliness and other indicators of
impaired social connectedness; these impaired social connections have been linked to reduced HIV adherence
and quality of life. The significant strain imposed on social relationships by COVID-19 restrictions and by
losses of family, friends, and community has brought urgency to the issue of social connections, particularly for
vulnerable populations such as those living with HIV infection. COVID-19 has also brought increased calls for
implementation of interventions focused on social connections, which in turn has highlighted a critical lack of
effective interventions in this area, rooted in evidence gaps regarding relationships between social connection
and health outcomes in diverse populations, in understanding of the unique and synergistic influences of
conceptually distinct dimensions of social connection on health over time, and on modifiable pathways linking
these connections to health outcomes. Applying a longitudinal, mixed-methods, and community-engaged
framework within a nationally-representative and well-characterized HIV cohort study, the MACS/WIHS
Combined Cohort Study (MWCCS), this project aims to: (Aim 1) characterize longitudinal and multidimensional
patterns of social connection both prior to and during the COVID-era, and identify social, behavioral and
genomic predictors of these patterns; (Aim 2) identify relationships between patterns of social connection and
HIV outcomes, including identification of mechanistic pathways via substance use disorders and depression,
and (Aim 3) assess multilevel mediators and moderators of relationships between social connection and
temporally associated outcomes including area-level socio-geographic indicators of poverty and population
density. This work utilizes the extensive platform of the MWCCS, including annual laboratory evaluation of HIV
disease indices, validated medication adherence measures, genome-wide data that will be utilized to construct
polygenic risk scores, annually updated geocoded data, and diagnostic assessments of substance use
disorders and depression (N=2000). To this, we will add an annual battery of social connection measures,
including social and emotional loneliness, social isolation, and social integration at selected MWCCS sites
(N=735), coupled with nested, longitudinal qualitative interviews (N=40). This multidimensional, longitudinal
and multilevel analysis will significantly extend previous research in this area, and findings from this project can
be utilized to identify actionable targets to support the design of effective interventions in this important area
and high priority population.

Public health relevance
PROJECT NARRATIVE Social connections are critical to human well-being, and people lacking in actual connections or who perceive that they are lacking these connections are more likely to suffer from substance abuse disorders and other mental health problems, and among those living with HIV infection, to have lower medication adherence and decreased quality of life. Applying a longitudinal, mixed-methods, and community-engaged framework in a nationally-representative study of persons living with HIV, and encompassing patterns of social connection both prior to and during the COVID-era, this project will examine understudied pathways linking social connections to substance use disorders and depression, and to HIV outcomes. A better understanding of these mechanisms will address a critical gap in the literature on social connections and will advance the ability to design effective interventions in this important area.